Instrumentation Development and Engineering Application Solutions (IDEAS) Shared Resource

The research and development activities of the Instrumentation Development and Engineering Application Solutions (IDEAS) resource are collaborative efforts with NIH Institute scientists that require the development of biomedical laboratory and clinical research systems, instrumentation, and methodologies. The majority of these collaborations require novel approaches and designs for which there are minimal established criteria or technical knowledge. IDEAS staff have in-depth technical experience in all phases of engineering research and development. With their collaborators, IDEAS staff review the clinical and biomedical sciences to formulate project specifications. IDEAS staff evaluate the theoretical and practical constraints, consider commercially available technologies, and finally propose various solutions. IDEAS responsibilities often continue with the hands-on design, implementation, testing, installation, training, documentation, and production of a custom research system or methodology. Current collaborative projects, as well as associated research studies, include:

1. 3D Printed Cover-Slip Holder for Preserving and Protecting Fixed Cells During Shipment
2. 3D Printed Illustrations Renderings for Vision-impaired Visitors of the Cajal Exhibit
3. 3D Printed Intubation Chamber for Studying Histone Binding Proteins
4. 3D Printed PDMS Wafer Mold for Media Diffusion in Time-course Studies
5. 3D Printing Resource Technology Hub
6. 3D-printed Mold to Cast Microarrays for Spheroid Embedding
7. AR Scientific Data Visualization
8. Adaptor to Hold a 10X Genomics GEM-Generation Chip in Place for Single Cell Sorting
9. Adjustable Inclined Plane for Evaluation of Pediatric Exoskeleton Control Modes
10. Agarose Molding Stamp for High-Throughput Zebrafish Imaging
11. Apparatus for Thermal and Mechanical Perception in Mice
12. Artificial Tick Feeding Chamber
13. Artificial Tick Feeding Chamber - Ornithodoros Hermsi
14. Assessing the Value of 18F-NaF PET-CT to Predict Calcium Content
15. Automated Functional Mapping of Somatosensation
16. Automation of Alcohol Vapor Chambers for Continued Air Supply
17. BETA Center
18. Behavior Box Mouse Whisker Monitoring for Neuronal Circuit Studies
19. Biomechanical Coupling of Skull and Brain for Magnetic Resonance Elastography Experiments
20. Bioreactor for Long-Term Culture of Cerebral Organoids
21. Bone Growth Plate Cartilage Pellet Culture Bioreactor
22. CUP Water Treatment Testing Apparatus
23. Cell Segmentation for Real-Time Measurement of Intracellular Oxygenation Concentration and Metabolism
24. Characterization of the Nociception Phenotype in Individuals with Intellectual Disability (ID)
25. Characterizing Spontaneous Movements in Mouse Pups
26. Conductive Polymer based Microelectroporation for High Efficiency Cell Transfection
27. Correlating MRI and Histopathology Using Patient-specific Prostate Mold
28. Custom Cover for Treating Cells with Light Inside a Multi-Welled Plate
29. Data Acquisition System for Multi-channel Imaging System
30. Development of a Handheld Optical Spectroscopy System
31. Diffusion Exchange Functional MRI
32. Direct Time of Flight (TOF) PET Scanner
33. Dish with a Grid Pattern of Reservoirs to Hold Zebrafish Larvae for Imaging
34. Disinfectant-compatible Storage Solutions for Clinical Equipment
35. Distortion Product Otoacoustic Emissions System
36. EPR Imaging of in vivo Oxygen Status Associated with Cancer Treatment Studies
37. Enrichment Device for Animal Behavior Experiments
38. Etching Array Patterns on Glass Slides for 3D Myotube Culture
39. Evaluation of Extracellular Matrix (ECM) Stiffness Around Tumor Using Atomic Force Microscopy (AFM)
40. Fabrication of Replacement Fittings for Reverse Osmosis Units in ORF Boiler Plant
41. Fabrication of a 3D-printed Ovary Dissection Mold for Gonadal Tissue Histological Study
42. Fixed-Head Mouse Whisker Monitoring for Neuronal Circuit Studies
43. Glymphatics MRI Phantom Development
44. Ground Squirrel Hibernation Automated Behavior Monitoring
45. High-throughput Video-based Assessment of Drosophila - Drug Efficacy
46. Homebased Biosensor for Monitoring COVID-19 Patients
47. Hydrogel-Like Applicator for Treating Surface Cancer on Organs with Complex Topologies
48. Imaging/Interrogation of Metastatic Colonization in Perfused Resected Liver
49. Improved Mosquito Housing Device to Evaluate Consequences of Pyrethroid Resistance Mechanisms on Aedes Aegypti Dengue Infections
50. Improved TUR Device
51. Incubation Chamber for Brain Tissue
52. Incubator for Optogenetic Applications
53. Instrumentation for Spinal Learning Studies
54. Laser Welder GMP for Hyperpolarized MRI
55. Light-sheet Microscopy of Drosophila Motor Neuronal Circuits
56. Liver Perfusion System
57. Low-cost Shoe Design for Pediatric Patients with Lower Extremity Impairments
58. MRI Elastography for Anisotropic Materials
59. Macaque Brain Mold for Histology
60. Machine vision enabled behavioral tracking for cross-species extrapolation
61. Microfluidic PNA-based HIV Detection
62. Mirror Neuron Network Dysfunction as a Biomarker
63. Mirror Neuron Network Dysfunction as an Early Biomarker of Neurodevelopmental Disorder
64. Mouse Cardiac Electrophysiology Recording System
65. Mouse Home-Cage Monitoring Device for Learning and Memory
66. Mouse Illumination System for Retinal Dystrophy Studies
67. Mouse Whisker Stimulation and Tracking During Neural Imaging Experiments
68. Multi-Animal FED Operant Device
69. Noninvasive Multispectral Imaging to Quantitatively Assess Tissue Vasculature
70. OCT - Adaptive Optics Retinal Imaging with Eye Tracking
71. PRiME - Cardiovascular Intervention
72. Placenta Real-time Oximetry Using NIR Spectroscopy
73. Placenta Real-time Oximetry Using Ultrasound and NIR Spectroscopy
74. Portable Low-Field Magnetic Resonance Imager
75. Precise Cell Injection System to Model Immune Cell Recruitment and Engament with Tumor Cells in Peritoneum Tissue
76. Prostate Tumor Fresh Tissue Guided Procurement Methods
77. Quantitative Evaluation of Dynamic Activity of HeLa Cells in Different Viability States Using Dynamic Full-field Optical Coherence Microscopy
78. Rapidscan CW EPR Imaging of Oxygen Status
79. Running Wheel Tachometer
80. SCORHE
81. SCORHE - Phenotyping and Behavioral Assays
82. SCORHE - Phenotyping and Seizure Detection in ATP1A3 Mutated Mice
83. SLO - Adaptive Optics Retinal Imaging with Eye Tracking
84. Signal Amplification by Reversible Exchange (SABRE)
85. Single-Cell Analysis of Rare Virus-Infected and Tumor Cells by FIND-Seq
86. Take-home Device for Handgrip Strength Measurements
87. Tenodesis Type Action Hand Prosthesis for Pediatric Rehabilitation
88. Therapeutic EMFs to Reduce Cell Growth in Glioblastoma Multiforme
89. Tissue Characterization and Oxygenation Measurement
90. Tissue Culture Matrix Casting for Spheroid Growth and Histology
91. Tissue Freezing Cassette
92. Tissue Vacutainer Device
93. UV Crosslinking Device (330nm) to Accurately Map Incorporated 4SU RNA-protein Interactions
94. Vessel Mimetics for Cancer Cell Culture
95. Vestibular Sensory Evoked Potentials System
96. Video Analysis System for Behavior and Activity Assessment of Fruit-Flies in High-Throughput Studies: Rare Genetic Disease Phenotyping
97. Video Monitoring System for Automated Detection of Pain Related Mice Behaviors
98. Video System for Mouse Visual Response Identification
99. Wearable Optical Platform for Assessment of Hemodynamic Changes
100. Whisker holder fixture for Local Field Potential (LFP) recordings
101. X-clometer - New Radiographic Marker
102. Zebrafish Intubation Chamber for Longitudinal Imaging